Establishment and regulation of the immune suppressive microenvironment in pancreatic cancer

Pancreatic cancer is characterized by an extensive immunosuppressive fibroinflammatory stroma. The
regulation of this fibroinflammatory reaction remains incompletely understood. As a result, attempts to target the
stroma in clinical trials have been largely unsuccessful. Further, immunotherapy only benefits a small number of
pancreatic cancer patients, as we do not fully understand the mechanisms of immune suppression in this
disease, and are thus unable to reverse them. The goal of this proposal is to contribute to our fundamental
understanding of the establishment, regulation and functional role of the pancreatic cancer microenvironment.
We will focus on fibroblasts and myeloid cells, abundant components of the microenvironment. Our preliminary
data show that, in response to oncogenic Kras expression in neoplastic or cancer cells, fibroblasts are
reprogrammed, and activate an inflammatory gene expression profile. Further, our preliminary data show that a
combination of JAK/Stat3 signaling and cancer-cell derived metabolites mediates fibroblast reprogramming, at
least in cell culture conditions. Here, we propose to investigate the mechanism of fibroblast reprogramming at
different stages of carcinogenesis using a combination of in vivo and in vitro, mouse and human systems (Aim
1). Further, we will investigate the effect of fibroblast reprogramming in mediating the establishment of the
suppressive immune microenvironment (Aim 2). Finally, we will explore modalities to reprogram fibroblasts to
prevent or reverse carcinogenesis (Aim 3). Together, the experiments proposed will shed light on the functional
regulation of the pancreatic cancer microenvironment, and potentially identify new approaches to target the
microenvironment as a component of combination therapy.

Public health relevance
Based on our preliminary data, activation of oncogenic Kras in the pancreas leads to fibroblast reprogramming, expansion of the myeloid compartment and establishment of an immune suppressive microenvironment. The major goals of this project are to study the mechanisms of fibroblast reprogramming and the role of fibroblast cytokines in the establishment and maintenance of the immune microenvironment. We will use a combination of genetically engineered mouse model and patient derived samples to maximize the translational relevance of our studies.